Organization and architecture of a consortium for cellular resolution analysis of Alzheimer's disease and comorbid dementias.

ABSTRACT (ADMIN CORE)
The Seattle Alzheimer’s Disease Brain Cell Atlas (SEA-AD) renewal proposal “A multimodal brain cell atlas and community
resource of Alzheimer’s disease and comorbid dementias” aims to expand on its initial phase to build a cellular and
molecular atlas of AD and comorbid dementias (AD/ADRD) and is closely linked to the NIH BRAIN Initiative Cell Atlas
Network (BICAN) neurotypical brain atlases. SEA-AD takes a highly collaborative multisite approach, with experimental
work centered at the Allen Institute and the University of Washington, but involving ten member Institutes to bring
together needed expertise in AD/ADRD donor recruitment and brain preparation, quantitative neuropathology, single cell
and spatial genomics, data analysis and online resource creation. The Administrative Core will build on the existing
programmatic infrastructure established in the first phase of SEA-AD to coordinate, manage and support the three
Research Projects, Data Core, and cross-site Working Groups.
Effectively managing goals across sites requires strong administrative leadership and organizational support. The
Administrative Core will provide the structure, leadership and operational management of SEA-AD, including project
management, strategic planning, progress reporting, fiscal management, and support for collaboration and
communication. A Steering Committee with membership across key Institutes and Projects will provide overall scientific
guidance and leadership, with an external Scientific Advisory Board to garner input from the AD research community. The
Administrative Core will also provide necessary management and support of Project Teams for each Project and Core,
which oversee the collaborative, standardized, and on-time data generation, data analysis, and the public data sharing
and online resource creation processes. It will provide similar support for essential cross-Consortium working groups to
ensure standardization across tissue sites, appropriate cohort selection, tight integration across data generated from all
Projects and Cores, and harmonization and joint data analysis between SEA-AD data and other single cell genomics
datasets/projects in the AD community.
Project management best practices, including milestone setting, progress reporting and tracking, collaborative software
programs, and a responsibility matrix will be applied to SEA-AD to ensure achievement of performance objectives and
milestones, optimized communication, and resource utilization and prioritization. Further, the Administrative Core will
support the implementation of standard operating procedures and quality control standards for data generation, data
processing, and analysis. Finally, the Administrative Core will implement and maintain fiscal, legal and subcontractor
management processes, and manage publication and authorship decisions and conflict resolution. Overall, the
Administrative core will provide the leadership and support to ensure that the project will achieve its goal to create a
catalytic, high impact community data resource to accelerate progress across the AD and AD/ADRD research communities.

Public health relevance
PROJECT NARRATIVE (ADMIN CORE) The Administrative Core will provide leadership and organizational structure to align the efforts of the member Institutions, researchers, Projects, Cores and Working Groups to meet the goals and milestones of the Seattle Alzheimer’s Disease Brain Cell Atlas (SEA-AD) consortium project. The primary role of the Admin Core is integrating, aligning and supporting the efforts of the three Research Projects (donor preparation, selection and quantitative neuropathology; transcriptomics and epigenomics; and spatial transcriptomics/proteomics) and the Data Core, to ensure overall project advancement and success. The Administrative Core will oversee the operational management including strategic planning, project management, progress reporting, fiscal management, manuscript and authorship planning, conflict resolution and support for collaboration and communication to create, integrate, and disseminate to the community a catalytic resource for molecular and cellular understanding of Alzheimer’s disease and comorbid dementias.